Risk Factors for Alzheimer's Disease Among Latinos: Relationships Between Cardiovascular Disease Risk, Acculturation, Small Vessel Disease, and Alzheimer's Biomarkers

PROJECT SUMMARY
Latinos/as are a large and growing segment of the United States older adult population and are at increased
risk for Alzheimer’s disease and related dementias (ADRDs) compared to non-Latino/a Whites. Evidence
suggests that Latinos/as are particularly susceptible to ADRD in the presence of cardiovascular disease risk
factors (CVDRFs). Several other factors (e.g., sex, acculturation, Alzheimer’s biomarkers) may influence the
degree to which CVDRFs are linked to ADRD risk. For example, our own preliminary data suggest that Latina
women with elevated CVDRFs are more likely to have mild cognitive impairment (MCI), an intermediate stage
between healthy cognition and ADRD, than men. Interestingly, less acculturation (i.e., maintaining Latino/a
culture and less adoption of Anglo-American culture) has been associated with better cardiovascular health,
particularly among women, but pilot data has linked lower acculturation to poorer cognition. Finally, Alzheimer’s
biomarkers are becoming more accessible but have not been thoroughly investigated among Latinos/as who
are more likely to have mixed Alzheimer’s and cerebrovascular pathology (brain damage linked to poor
cardiovascular health) as opposed to pure Alzheimer’s pathology. The overarching goal of the proposed study
is to develop a comprehensive characterization of cognitive impairment and ADRD risk among middle-age and
older Latinos/as. To achieve this, the proposed project will incorporate psychosocial (i.e., acculturation) and
biological [i.e., CVDRFs, small vessel disease (a marker of cerebrovasculature), and Alzheimer’s biomarkers]
factors to study longitudinal cognitive change among Latinos/as 50+ years old. More specifically, the proposed
project will examine detailed cognitive data from the Study of Latinos- Investigation of Neurocognitive Aging
(SOL-INCA), SOL-INCA MRI (magnetic resonance imaging), and SOL-INCA AD (Alzheimer’s disease),
ancillary studies to the Hispanic Community Health Study/Study of Latinos (HCHS/SOL). In aim 1 we seek to
characterize gender-specific associations between acculturation and MCI, and test if CVDRFs underly the link
between acculturation and MCI status in over 6,000 Latinos/as. In aim 2 we will use gender-specific analysis to
determine if small vessel disease accounts for the relationship between CVDRFs and MCI/dementia status
(while accounting for acculturation); projected n = 2,400. In aim 3, we will examine whether acculturation or
Alzheimer’s biomarkers influence the relationships between small vessel disease and MCI/dementia status;
projected n = 2,400. The proposed K08 project will provide the candidate the tools necessary to continue
investigating Latino/a cognitive aging and ADRD risk through the National Institute on Aging’s Health
Disparities Framework as an independent clinical scientist.

Public health relevance
PROJECT NARRATIVE Latinos/as face Alzheimer’s disease and related dementias (ADRD) disparities and are projected to see the largest increase in United States dementia cases by 2060. To address this impending public health crisis, the proposed project will examine longitudinal changes in cognition based on cardiovascular disease risk, acculturation, small vessel disease, and ADRD biomarkers among diverse Latinos/as 50+ years old. Using a biopsychosocial approach, this project will provide nuanced characterization of risk factors for ADRD in this population which may lead to better informed clinical care, novel interventions, and may ultimately reduce ADRD disparities in this population.